Investigating TFEB as a critical node to improve proteostatic maintenance and skeletal muscle function with age

PROJECT SUMMARY/ABSTRACT
Skeletal muscle atrophy and dysfunction are a hallmark of aging, sarcopenia, and disuse atrophy that
significantly affect individual health span and quality of life. There are currently no effective treatments for age
related muscle dysfunction because underlying mechanisms that contribute to muscle pathology are not fully
understood. A recently published manuscript from the PI shows that protein synthesis and mTOR activity, a
primary regulator of protein synthesis, is high in aged muscle, likely inhibiting TFEB (transcription factor EB)
nuclear translocation and subsequent activity. This finding suggests that impaired protein degradation, not
protein synthesis, compromises maintenance and recovery of aged muscle. We also showed that there was an
accumulation of insoluble ubiquitinated proteins and p62 protein in the insoluble fraction of old muscle.
Together, these data suggest that compromised autophagy dependent protein degradation likely impacts
skeletal muscle function in aged muscle with sarcopenia and recovery after disuse atrophy. The goal of this
project is to determine if TFEB functions as a critical node in muscle maintenance with sarcopenia and
recovery with disuse atrophy in aged muscle. TFEB stimulates lysosomal biogenesis and autophagy, which are
essential in targeted protein degradation and therefore proteostatic maintenance. The hypothesis of this
proposal is that TFEB functions as a critical node to improve maintenance and recovery of skeletal muscle
mass and function with aging in two conditions of muscle dysfunction, sarcopenia and disuse atrophy. The
following Specific Aims are proposed to test the hypothesis: Aim 1: Determine if increasing TFEB activity
improves maintenance of muscle mass and function in aged mice. Aim 2: Determine if mTOR activity regulates
TFEB-dependent preservation of proteostatic maintenance and muscle function. Aim 3: Test whether
increasing TFEB activity can improve recovery of muscle after disuse atrophy in aged mice. If results support
the hypothesis, TFEB may be a novel therapeutic target to protect against sarcopenia and improve recovery
with disuse atrophy in aged skeletal muscle.
The principal investigator (PI) of this grant is a postdoctoral fellow under the mentorship of Dr. Benjamin
Miller at Oklahoma Medical Research Foundation (OMRF). The PI will learn state-of-the-art genetic, molecular,
and physiological techniques in mouse and Drosophila melanogaster (fruit flies) to test the effects of TFEB on
skeletal muscle proteostasis, in vivo and ex vivo muscle function, protein turnover with stable isotopes, and
large proteomics data set bioinformatics analysis. The PI will learn these novel techniques from the mentoring
team consisting of Drs. Benjamin Miller, Holly Van Remmen, Fabio Demontis, and Wan Hee Yoon. The
mentoring team will monitor the progress of the PI and will also give advice for starting a new laboratory,
recruiting members to the PI’s laboratory, and mentoring future scientists as the PI transitions towards
research independence.

Public health relevance
PROJECT NARRATIVE Millions of aged individuals suffer from loss of skeletal muscle mass and function because of sarcopenia and disuse atrophy. Despite the impact sarcopenia and disuse atrophy have on subsequent quality of life and healthspan, no pharmacological therapies are currently available because the underlying mechanisms that trigger muscle dysfunction are not fully understood. This proposal will explore the novel concept that TFEB functions as a critical node to improve maintenance and recovery of skeletal muscle function in two conditions of muscle loss, sarcopenia and disuse atrophy.